Auxin Response Factors as a model of transcriptional control

Project Summary
Hormone-mediated modulation of gene activation or repression through transcription factors is central to all
organisms. AUXIN RESPONSE FACTOR (ARF) transcription factors are critical modulators of plant growth
and provide an ideal model for exploring hormone control of gene activation and repression. Of the 23-member
ARF family, five are considered transcriptional activators and 18 are considered transcriptional repressors,
allowing for study of both activator and repressor activities in a single family.
Under low auxin concentrations, Aux/IAA proteins repress ARF transcription factors via direct interaction
and recruitment of chromatin remodeling factors. When auxin concentrations are high, a co-receptor complex,
comprised of an F-box protein from the TRANSPORT INHIBITOR REPONSE1 (TIR1) family and an Aux/IAA
repressor protein, directly binds auxin. The F-box protein participates in a Skp1-Cullin-F-box (SCF) E3 ubiquitin
ligase, which targets the Aux/IAA protein for degradation. This degradation event relieves ARF transcription
factor repression, allowing auxin-regulated transcription. This receptor-ligand interaction allows a very short
signal transduction chain to facilitate rapid transcriptional responses to auxin.
To understand the molecular underpinnings of ARF-ARF and ARF-Aux/IAA interactions, our lab first solved
the structure of the interaction domain, finding that it folds into a Type I/II PB1 domain. Within this domain,
positively charged and negatively charged electrostatic faces occupy opposing sides, creating a miniature bar
magnet that allows for front-to-back oligomerization in the packed crystal, in solution, and in the plant.
Our lab further discovered that activity of a subset of ARFs is regulated by protein condensation driven by
the combination of PB1 oligomerization and an intrinsically disordered region. Biomolecular condensation of
these ARFs modulates auxin responsiveness in a developmentally-relevant context. We further found that
many ARFs are regulated by proteasomal degradation, have identified an E3 ubiquitin ligase involved in this
process, and determined that ARF stability is regulated by environmental conditions. Finally, ARF interactions
are easily manipulated using PB1 domain point mutations, allowing us to direct ARF interactions for study.
Using ARFs as a model will allow us to interrogate transcription factor function in an easily manipulated system
to yield broad insight into many transcription factors.
We are aided in our efforts by our multidisciplinary approach, extensive auxin-related molecular toolkit, and
unique reagents generated by our lab. Our lab’s expertise in genetics and biochemistry/biophysics, combined
with our discoveries of ARF condensation, nucleo-cytoplasmic partitioning, and proteasomal degradation,
makes us well positioned to drive forward our understanding of biomolecular condensation and other
mechanisms in regulation of transcription factor activity.

Public health relevance
Project Narrative Our research is relevant to the NIH mission to seek fundamental knowledge about the nature and behavior of living systems. We seek to understand hormone-mediated modulation of gene activation or repression through transcription factors. Because this process is central to all systems, identifying mechanisms that regulate transcriptional activity in one organism may be broadly informative to all organisms.